Cancer Center Support Grant

Kaposi’s sarcoma (KS) is a human malignancy associated with Kaposi’s sarcoma-associated herpesvirus (KSHV). KS continue to be the most common HIV-associated cancer world-wide. KS lesions are characterized by proliferating endothelial-derived spindle cells, leaky blood vessels, and inflammatory infiltrating leukocytes. Within these lesions, inflammatory leukocytes secret cytokines and growth factors that KSHV-infected cells rely on for growth and survival. KSHVinfected endothelial cells promote the infiltration of inflammatory cells by modulating the expression of adhesion factors on its surface. We have found that KSHV infection induces the expression of novel endothelial adhesion factors and increases leukocyte adhesion and transendothelial migration. We propose to determine the mechanism by which KSHV induces leukocyte adhesion and transendothelial migration and validate the biology of this process using tissue specimens from the AIDS and Cancer Specimen Resource (ACSR). Our proposal will also identify new targets for therapies against KS in HIV-infection individuals.

Public health relevance
PROJECT NARRATIVE The Lineberger Comprehensive Cancer Center (LCCC) forms the nexus for researchers focused on understanding and identifying the mechanisms leading to, the prevention of, and treatments for cancer. LCCC is an integral component of the research mission at The University of North Carolina (UNC) at Chapel Hill, coalescing the cancer research capabilities of the Schools of Medicine, Public Health, Pharmacy, and Nursing, and the College of Arts and Sciences. The LCCC strives to reduce cancer incidence, morbidity, and mortality in North Carolina, the United States and across the globe through innovative research, cutting-edge treatments, multi-disciplinary training, education and outreach.